Measuring Responsivity in Individuals with Profound Intellectual Disability

Project Summary/Abstract
Profound intellectual disability (PID) is characterized by limited conceptual skills, limited understanding of
symbolic communication, and total dependence on others for self-care. At present, there are no valid measures
of cognition that are sensitive to the range of functioning in individuals with PID; however, these tools are critical
in informing clinical care, person-centered educational/day planning, and clinical trial readiness for this group.
This proposal includes a career development plan to support the PI in acquiring the knowledge and skills
necessary to develop patient-focused clinical outcome assessments (COAs) for individuals with PID. This
expertise is critical to fill the substantial gap in cognitive and functional measures available for this underserved
and understudied group. Training will focus on 1) qualitative and 2) quantitative aspects of measure
development, 3) an understanding of regulatory control as it pertains to the implementation of COAs in clinical
trials as well as ethical considerations in conducting research in this group, 4) skills in partnering with patient
advocates to promote diverse representation in research and 5) skills in effective academic writing and
leadership. Preliminary data support that a foundational aspect of cognition, responsivity, is a meaningful
indicator of functioning for individuals with PID as reported by their caregivers. The proposed research study will
utilize both qualitative and quantitative methods to develop a novel performance measure (PerfO) and observer-
report measure (ObsRO) of responsivity intended for individuals with PID through the following aims: 1) Refine
the concept of “responsivity” within the context of PID. A concept elicitation approach will be used to develop a
reflective model of responsivity for PID through expert panels and caregiver interviews. 2) Develop a novel PerfO
and ObsRO of responsivity for individuals with profound ID. Co-design methods including an expert workgroup,
caregiver interviews, and pilot testing will be used to modify measures of responsivity developed for individuals
with acquired brain injuries in this pursuit. The primary goal of development is to create feasible, valid, and useful
measures of responsivity with the potential to capture meaningful change in individuals with PID. Secondary
goals include maximizing appropriateness for a broad age range and ease of future adaptation (e.g., for specific
genetic etiologies, remote administration). 3) Describe the psychometric properties of the novel PerfO and
ObsRO. Psychometric aspects including feasibility, central tendency and dispersion, reliability, validity, and
provider perceptions of utility will be examined for both measures. An exploratory sub-study will utilize qualitative
and quantitative methods to examine caregiver perceptions of meaningful change on both measures. Through
the achievement of these study aims and related training activities, the PI will obtain the mentorship and training
needed to become an independent clinician-scientist in measure development and validation for individuals with
PID.

Public health relevance
Project Narrative There are currently no validated measures of cognition that are sensitive to the range of functioning in individuals with profound intellectual disability (PID); however, these tools are critical for clinical care, person-centered services, and research contexts. This proposal seeks to develop novel performance (PerfO) and observer-report (ObsRO) measures of cognition that provide meaningful information about current functioning and have the potential to capture meaningful change in individuals with PID. The intent is that these measures will not only facilitate improved clinical care and services for individuals with PID but also support the development of novel treatments that will improve quality of life in this underserved group.